Impact of mutation burden on cancer growth and the immune landscape

PROJECT SUMMARY/ABSTRACT

Immune checkpoint blockade (ICB) using antibodies that disrupt PD1 or CTLA4 signaling can lead to durable
responses in a wide variety of human cancers. Unfortunately, only a minority of patients obtain clinical benefit
from ICB. A high non-­synonymous nuclear mutation burden has been correlated with increased likelihood of
response to ICB, suggesting that mutation induced neoantigens may underlie the tumor associated activation
of immune checkpoints. Although this hypothesis linking mutation burden to peptide neoantigens is compelling,
it has not been completely validated. Moreover, elevated mutation burden does not always dictate response to
ICB, with some low mutation tumors such as thyroid cancers showing responses. Thus, there are huge gaps in
our knowledge of the underlying mechanisms dictating response to ICB. We hypothesize that a high
background somatic mutation burden, through introduction of mutations in DNA polymerases, will alter the
immune landscape of cancers through the presence of truncal, tumor specific “neoantigens” that confer
response to ICB. We will test this hypothesis and decipher underlying mechanisms using novel mouse models,
This will be approached through the following specific aims: Aim 1: Determine the nature of the immune
response to cancers with endogenous high nuclear mutation burden arising spontaneously in mice harboring
germline proofreading mutations in Pold1 and Pole and patient tumors harboring POLE and POLD1
mutations.;; Aim 2: Determine how a high nuclear mutation burden affects the growth of oncogene-­driven
autochthonous cancer models and sensitivity to immune checkpoint therapy;; Aim 3: Determine if proofreading
mutations in Polg and elevation of mitochondrial genome mutation burden contributes to an anti-­tumor immune
response.. Aim 4: Determine how combining targeted therapy and immune checkpoint therapy are modulated
by presence of high background mutation burden. To address these aims, we will utilize mouse models in
which a high background mutation rate is induced through germline proofreading mutations in Pole and Pold1
(for nuclear mutations) and Polg (for mitochondrial mutations. We will compare how specific oncogenes (Braf
in skin and lung, and Kras in lung) induce tumors in either wild type mice or in mice with germline proofreading
polymerase mutations to determine how high background mutation rate alters tumor growth, local and systemic
immune response, and response to targeted therapy and ICB. Our overall goal is to develop a better
understanding of how mutation burden affects the immune response to solid tumors. Robust models of high
mutation burden cancers can be used to guide rational development of combination treatment strategies that
can be translated into the clinic.

Public health relevance
PROJECT NARRATIVE Although immunotherapy has had remarkable successes in the treatment of cancer, it only benefits a minority of cancer patients, and we do not know how to rationally combine immunotherapy with other treatments. Advances have been difficult in part because we do not have animal models that respond well to immunotherapy. The goal of this project is to develop better mouse cancer models that harbor both the driver and passenger mutations seen in human cancers, and use this to understand mechanisms of response and resistance to immunotherapy and rationally design more effective combination immunotherapy strategies.